Advanced Development of TIES-Enhancing Access to Tissue for Cancer Research

DESCRIPTION (provided by applicant): Archived human tissues are an essential resource for translational research. Formalin-fixed, paraffin-embedded (FFPE) tissues from cancer patients are used in a wide range of assays, including RT-PCR, SNP profiling, multiplex biomarkers, imaging biomarkers, targeted exome, whole exome, and whole genome sequencing. Remainder FFPE tissues generated during patient care are 'retrospective'; use of these tissues under specific conditions does not require consent. For personalized medicine researchers, these specimens are vital resources enabling biomarker validation, detailed molecular analysis, and systems modeling before application is made to individual patients. But access to these human tissues is often a rate limiting factor in cancer research. We propose advanced development of the TIES software to (1) increase institutional capacity for using FFPE to support molecular characterization of human tumors, (2) increase access to tissues within cancer centers, and (3) improve the ability to share tissues and associated phenotype data among cancer centers.

Public health relevance
PUBLIC HEALTH RELEVANCE: This work proposes the development of a software system that will enhance the ability of cancer researchers to find and use human tissues and accompanying electronic data for scientific research. By increasing access to tissues and data, this work seeks to increase the speed of scientific discoveries that will ultimately impact cancer patients.